Candida albicans Sap6 dysregulates host epithelial protease-antiprotease expression

Candida albicans is an oral commensal yeast that can cause mucosal (oral or OPC) and systemic (invasive)
infections. Candida mucosal infections are emerging as major public health threat in the US due to higher
treatment costs and increased mortality rates particularly among the immunocompromised and critically ill.
Thus, there is an urgent need for improved prevention and treatment of mucosal candidiasis. C. albicans
hyphal colonize or invade oral epithelial cells that are the first line of physical and immunological defense. C.
albicans produces secreted aspartyl proteases (Sap4-6) that counter epithelial immune responses through
their proteolytic activity. OECs treated with recombinant Sap6 protease resulted in increased epithelial
permeability, increased IL-8, IL-1β release, increased epithelial migration and altered levels of host proteases
(kallikreins, matrix metalloprotease and ADAMs). However, we do not know the mechanism by which C.
albicans hyphae and Sap6 change host proteases in OECs or which proteases are required for increased
fungal invasion, inflammation or changes in OEC migration. Therefore, the Specific Aims of this proposal will
1) Determine how C. albicans Sap6 modifies OEC Kallikrein activity and barrier function, and 2) Examine the
role of MMP/ADAM levels on migration of OECs infected with C. albicans or Sap6. The expected outcomes of
this work will establish host Kallikreins and matrix metalloproteases as important factors for C. albicans -
epithelial interactions and define their role in modulating host inflammatory responses to Sap6 in OECs. Our
long-term goal is to understand how C. albicans exploits host proteases/antiproteases to induce acute or
chronic immune responses. This will provide much needed ground work to identify host proteases as new
therapeutic targets for treating acute and chronic inflammation caused by oral microbes.

Public health relevance
Oral epithelial cells serve as both physical and immunological barriers against the oral pathogen Candida albicans that can be damaged by the secreted aspartyl protease Sap6 produced by C. albicans hyphae. This study will investigate how Sap6 impairs oral epithelial physical and immunological barriers by modifying host protease-antiprotease levels and increasing host inflammatory responses. The outcome of this study will aid in development of new therapeutic strategies that target host inflammatory proteases leading to the improvement of oral health.